WORLD WIDE WEB HOME PAGE: CARBON ISOTOPES &NMR SPECTROSCOPY

Our World Wide Web Home Page was created this past year. By following the links from our Home Page, one can find: a description of our research emphasis on carbon isotopomer analysis and intracellular cations; a list of the Facility's personnel, users, and contacts; available "products" with brief descriptions of tcaSIM, tcaCALC, TmDOTP5-, and our 3 day training course, as well as who to contact to obtain more information about these items; the annual symposium announcement with the program, speakers, symposium site, and registration information; and a few representative publications. Our Home Page is at URL http://www.swmed.edu/home_pages/rogersmr.